Targeting the RNA modifying enzyme ALKBH5 in Medulloblastoma

Abstract
Medulloblastoma is the most common malignant childhood brain tumor, which accounts for large number of all
childhood cancer deaths. MB are very fast-growing tumors, which spreads to central nervous system (CNS)
through cerebrospinal fluid, which leads to leptomeningeal metastases that occurs up to 66% in brain cancer
patients. Despite the progress in treating MB, the 5-year survival rate for high-risk MB remains poor with high
recurrence. Moreover, the quality of life for those kids who do survive is substantially reduced due to the high
toxicity associated with the high radiation exposure and multiple drug chemotherapy they must endure at such
an early age. Therefore, it is critical to identify novel factors and understand previously undefined mechanisms
that drive MB growth and progression, so that safe and viable therapeutics can be developed for treating MB. In
this proposal, we provide compelling evidence that RNA demethylase ALKBH5 may play an important role in MB
growth and progression by supporting MB cancer (tumor initiating) stem cells (MB-CSC) and thus serve as a
novel therapeutic target. Our preliminary results revealed that MB cells are highly dependent on ALKBH5 for its
survival. Using multiple MB cell lines with or without ALKBH5 depletion, we discovered that depletion of ALKBH5
inhibited both short and long-term growth of MB cells. In addition, depletion of ALKBH5 inhibited the migration
of MB cells. Importantly, we show that ALKBH5 silencing suppressed the self-renewal/proliferation of MB stem
cell. Supporting that, ALKBH5-depletion led to significantly decreased levels of cancer stem cell markers. These
are significant findings as MB stem cells are considered to be the major source of MB initiation, maintenance,
relapse and render MB cells resistant to radiation. These observations led us to hypothesize that RNA
demethylase ALKBH5 supports MB growth and progression by promoting cancer stem cell self-renewal; and
those approaches aimed at targeting ALKBH5 level/activity will sensitize radiation response in MB patients. To
test these hypotheses, we propose following two Specific Aims: In aim#1, To establish the role of ALKBH5 as a
promoter of MB growth and progression. In aim#2, To determine the mechanism by which ALKBH5 regulates
MB stemness and growth by identifying and characterizing ALKBH5 target genes and their m6A status in MB
cells. Successful completion of this proposal will indicate RNA epigenetics as an important regulator of
medulloblastoma stem cell viability and self-renewal. Given that ALKBH5 knockout mice is reported to be viable
and our preliminary studies showing high dependency of MB cell survival on ALKBH5 suggest that ALKBH5 may
serve as a novel and safe therapeutic target for treating MB patients.

Public health relevance
Project Narrative Medulloblastoma (MB) is the most common malignant childhood brain tumor, which accounts for large number of childhood cancer deaths. Despite the progress in treating MB, the 5-year survival rate for high-risk MB remains poor with high recurrence. These is a significant need to identify novel targets that treat the MB effectively with less side effects. We discover that RNA demethylase ALKBH5 may play an important role in MB growth and progression and therefore may serve as a novel therapeutic target.